2022 Proteoglycans Gordon Research Conference and Gordon Research Seminar

PROJECT SUMMARY/ABSTRACT
From the inception of the Proteoglycans (PGs) Gordon Research Conference (GRC) in 1984, this biennial
meeting has become an essential meeting for PG researchers. It is now recognized as the leading international
forum for PG and glycosaminoglycan (GAG) research. Key to its success is its strong history as a meeting with
a collegial atmosphere that fosters the dissemination of unpublished and emerging research that stimulates
scientific discussions and collaborations among attendees. This proposal is requesting partial support for the
next PGs GRC, “Frontiers in Basic and Translational Proteoglycan Research to Improve Human Health,” which
will be held from July 10th to July 15th, 2022 and the associated PG GRS entitled, “Integrated Proteoglycan
Research to Improve Human Health,” to be held on July 9th - 10th, 2022 at Proctor Academy, Andover, NH. The
conference program was developed with the input from the Advisory Committee consisting of past Chairs of PGs
GRCs plus organizers of meetings for the international conferences on PGs (ICP) and the International Society
for Hyaluronan Sciences (ISHAS). This committee provides expertise across a broad area, including
fundamental, translational, and clinical PG research. The meeting program developed with the help of the
advisory committee will bring together highly regarded scientists performing high-impact PG research, some of
whom will be attending this meeting for the first time. The invited scientists will present the latest findings in
fundamental PG research addressing biosynthesis, catabolism, and technological advances in the field. A major
focus of this GRC will be presentations highlighting PGs as therapeutic tools and targets. To provide early-stage
investigators an opportunity to highlight their research, the meeting program includes short talks and poster
sessions. Short talks will be selected from abstracts to be complementary to the theme of a session. The scientific
program aims to present state-of-the-art science to spark scientific discussions and collaborations, leading to
the generation of new ideas, innovative research projects, and new grant proposals. The organizers have and
will continue to pay careful attention to ensure equal gender representation of speakers and discussion leaders
and increase the number of underrepresented groups in all aspects of the conference. Additionally, a discussion
of gender issues/impediments in scientific career development will occur in the one-hour session entitled “Power
Hour.” Attendees of this meeting will be selected by invitation or from the applications submitted online, with
careful attention paid to develop a demographically diverse and inclusive meeting. Based on previous attendance
to the PGs GRC, we expect approximately 200 attendees.
1

Public health relevance
NARRATIVE Proteoglycans play a crucial role in modulating critical cellular processes, including cellular differentiation, proliferation, growth, adhesion, migration, autophagy, angiogenesis, and survival under developmental, physiological, and pathological conditions. The 2022 Proteoglycans GRC and GRS will highlight the latest findings in fundamental and translational proteoglycan research and will underscore proteoglycans as therapeutic tools and targets. With a strong history as a meeting with a collegial atmosphere that fosters collaborations among PG scientists, this conference will inspire the next generation of PG researchers and facilitate discussions leading to the generation of new ideas, innovative research projects, new grant proposals, and potential therapeutic strategies targeting proteoglycans. 1